Role of Histone Deacetylase 4 in Alcoholic Liver Disease

PROJECT SUMMARY
Alcoholic liver disease (ALD) is a major cause of morbidity and mortality worldwide. ALD is the eighth most
common cause of mortality in the U.S. and the second leading cause of death among all gastrointestinal
diseases. Alcoholic hepatitis (AH) is the progressive form of ALD, which can progress to cirrhosis and
hepatocellular carcinoma. Therefore, there is an unmet need for developing effective therapeutic strategies for
AH. Evidence suggests histone deacetylases (HDACs) are involved in alcohol-induced cell damages. However,
little is known about the role of each HDAC isoform in the pathogenesis of AH. We found that HDAC4 mRNA
and protein levels were markedly increased in the human liver with alcoholic cirrhosis and the mouse
liver exposed to alcohol. Furthermore, our preliminary data indicate that ethanol increased HDAC4
expression in Huh-7 cells, a human hepatocellular carcinoma cell line. Also, ethanol induced the expression
of Hdac4 with concomitant increases in inflammation and oxidative stress in macrophages, which was
significantly attenuated when Hdac4 was knocked out or down. Sirtuin 1 (SIRT1) is known to prevent
alcohol-related cell damages and liver injury. Consistently, we found that a SIRT1 inhibitor increased
interleukin-1b (Il1b) expression, whereas a SIRT1 activator significantly abolished ethanol-induced
Hdac4 and Il1b expression in macrophages. It is of interest that Hdac4 deficiency increased Sirt1
expression, while human HDAC4 overexpression elicited the opposite effects in RAW 264.7
macrophages. The preliminary results suggest the HDAC4/SIRT1 axis may play a crucial role in the
development of AH. Based on the strong premise described above, we establish the central hypothesis that
the deletion of Hdac4 in hepatocytes or macrophages inhibits the development of AH by altering hepatic
expression of genes, including SIRT1, that are critically involved in alcohol-induced inflammation and oxidative
stress. We will take both targeted (SIRT1 pathway) and untargeted approaches (genome-wide transcriptome
analysis) using novel mice that have hepatocyte- or macrophage-specific deletion of Hdac4 under chronic-binge
ethanol feeding (the NIAAA model) as in vivo models. We will test the hypothesis by pursuing the following two
Specific Aims: 1) to determine the role of hepatocyte and macrophage HDAC4 in the development of AH and
to evaluate the HDAC4/SIRT1 axis for the pathogenesis of AH; and 2) to conduct a genome-wide transcriptome
analysis to identify HDAC4-regulated genes in hepatocytes and macrophages that mediate the pathogenic
processes of AH and to corroborate the findings using human liver specimens and primary human hepatocytes
and macrophages. The findings from this exploratory study will produce much-needed information on the role of
hepatocyte and macrophage HDAC4 in the pathogenesis of AH. Also, this study will lead to the discovery of new
genes/pathways, which can be exploited for future therapies for AH. Therefore, a significant impact on public
health is anticipated upon completion of this study.

Public health relevance
PROJECT NARRATIVE Alcoholic hepatitis is the progressive form of alcoholic liver disease that can progress to cirrhosis and hepatocellular carcinoma. However, the lack of our understanding of the molecular mediators and pathways leading to alcohol-induced liver injury has been a major barrier to the development of an effective therapeutic strategy for alcoholic hepatitis. By capitalizing on our previous observations that support a potential role of histone deacetylase 4 (HDAC4) in the pathogenesis of alcoholic hepatitis, the primary objective of this project is to identify biomarkers/molecular signatures that play crucial roles in alcohol-induced liver injury under the regulation of HDAC4.